Role of FABP5 in COPD Exacerbations

PROJECT SUMMARY
Inflammation underlies the pathogenesis of many chronic lung diseases. Thus, defining mechanisms by which
pulmonary inflammation is regulated and resolved is of high clinical importance. Understanding those
mechanisms is especially relevant to chronic obstructive pulmonary disease (COPD), a condition that typically
develops following decades of cigarette smoking (CS) and in which repeated respiratory infections are linked to
non-resolving inflammation and can cause disease flares (COPD exacerbations). Lung macrophages are critical
for both initiation and resolution of inflammation, and the control of exacerbations. They can adopt different
phenotypes (i.e., pro-inflammatory or pro-repair) that are characterized by an interplay of transcriptional and
metabolic programming dictating macrophage function and ensuring tissue integrity. We previously
demonstrated that fatty acid binding protein 5 (FABP5) mediates pro-repair macrophage function via interaction
with the nuclear receptor Peroxisome Proliferator-Activated Receptor γ (PPARγ) and identified a novel single
nucleotide polymorphism (SNP), rs202275, linked with a FABP5 enhancer region and COPD exacerbations.
However, the critical role of the FABP5/PPARg axis and the genetic variation rs202275 (T) in macrophage
phenotypic programming and whether they can be targeted for therapeutic purposes remains unknown. We
propose 3 aims to interrogate the role of the FABP5/PPARg axis in macrophage pro-repair phenotype relying on
1) metabolism, 2) transcription, and 3) function of lung macrophages. This work will provide an in-depth clinically
relevant understanding of the mechanisms by which decreased FABP5 leads to chronic lung inflammation in
COPD exacerbations, identify a novel target to reverse chronic inflammation in COPD, and validate the
repurposing of FDA approved PPARγ agonists used in type 2 diabetes.

Public health relevance
PUBLIC HEALTH RELEVANCE Chronic Obstructive Pulmonary Disease (COPD) is among the most common and costly public health problems worldwide. While cigarette smoke is the predominant risk factor for the development of COPD, repeated infections contribute to persistent inflammation and progression of the disease. Our research proposal focuses on the role of lung macrophages in propagating chronic inflammation in patients with COPD exacerbations.